Use of Registries, Claims and Health System Data to Enhance the Evaluation of Cardiovascular Devices

PROJECT SUMMARY/ABSTRACT
There is an urgent need to develop and implement more efficient approaches to evaluate
cardiovascular devices in representative patient populations. Data from registries, health care systems,
and payers, often include detailed clinical baseline information and longitudinal outcomes on a large number of
patients representative of those cared for in clinical practice. However, the most commonly performed non-
randomized evaluations using these data have high risk of bias due to a number of methodological challenges,
including unmeasured differences between patients receiving different treatments (confounding) and
misalignment of treatment eligibility, treatment initiation and beginning of follow up (selection bias). Thus, there
is great enthusiasm for exploiting newer study design and analysis strategies that can more closely
approximate the results of a desired but yet-to-be-performed randomized trial, while gaining the efficiency and
representativeness of using data routinely collected in the course of patient care. Applying state-of-the-science
methods to diverse and rich datasets may identify specific populations with different responses to device
treatment - a key step in the ability to deliver individualized patient-centered care. In this renewal application,
we will continue to pursue the overarching goal of developing innovative approaches to enhance the
efficiency, fidelity and generalizability of cardiovascular device evaluation through the analysis of
unique multidimensional linked datasets. In Aim 1, we will apply new methods to transport inferences about
treatment effects from pivotal randomized trials of high-risk cardiovascular devices to new target populations
representative of patients seen in contemporary practice. In Aim 2, we will evaluate the safety and
effectiveness of high-risk cardiovascular devices through application of the target trial framework, a set of
conceptual and practical tools for designing observational emulations of randomized trials that is well suited to
overcome common forms of selection bias (e.g., immortal time bias) in cardiovascular device comparisons. In
Aim 3, we will apply quasi-experimental methods to evaluate the safety and effectiveness of these devices,
including instrumental variable and instrumented difference-in-difference designs. In each of the three aims, we
will develop and apply methods to examine subgroups of patients under-represented in trials, specifically
women, Black patients, and patients from socially disadvantaged communities. This research will inform the
safety and effectiveness of several cardiovascular devices that have not been well studied, provide important
clinical information to practicing physicians in the community, and create new standards for the future
regulatory evaluation of medical devices using transportability, observational, and quasi-experimental
approaches to complement standard randomized trials.

Public health relevance
PROJECT NARRATIVE Understanding whether cardiovascular devices are safe and effective for different groups of patients is an important public health and clinical concern. The overall goal of this proposal is to evaluate how the large amounts of data collected each day in the routine course of clinical care can best be used to study commonly used devices to treat serious heart conditions. The study will use state-of-the-science approaches for data analysis to examine whether several high-risk cardiovascular devices are being used safely and effectively in the United States today, including among patient subpopulations that are rarely included in clinical trials. The results of this research will determine how ubiquitous data collected by registries, health systems and payers, and advanced causal inference methods, can best be combined to improve our present and future understanding of new medical devices.